Integrated Health Sciences Facility Core

PROJECT SUMMARY - INTEGRATED HEALTH SCIENCES FACILITY CORE (IHSFC)
The Integrated Health Sciences Facility Core (IHSFC) promotes human-centered research on susceptibilities,
pathways of toxicity, disease, clinical treatment, and precision environmental health, with the overarching goal
to enhance the careers of Center investigators and translating new insights related to rural exposures to
population health. Successful accomplishment of this goal requires a state-of-the-art infrastructure that
addresses the critical need of investigators to design and implement translational research with safety to both
research subjects and investigators, reproducibility, and rigorous scientific approaches. In conjunction with the
Community Engagement Core, the IHSFC enhances environmental health literacy and public health practice
and facilitates the translation of findings relevant to environmental health science (EHS) bi-directionally along
the spectrum from basic or clinical research to the applied or public health arenas. The Specific Aims of the
IHSFC are Aim 1) to provide the infrastructure to carry out clinical and translational studies relevant to EHS,
including a) providing resources to assist in obtaining approval for the use of human subjects for clinical and
translational studies relevant to EHS; b) recruiting human subjects for clinical and translational studies relevant
to EHS; c) assessing and monitoring pulmonary and systemic physiologic responses; d) assessing and
quantifying radiographic manifestations of lung injury (airway and parenchymal) and physiological responses; e)
addressing rigor and reproducibility by providing biostatistical support to all member; and f) providing ecological
momentary assessment and health-symptom sampling for environmental health researchers using mobile
devices. The IHSFC will: Aim 2) ensure that clinical and translational studies relevant to EHS are carried out
safely, and that subject confidentiality is maintained; Aim 3) develop engaged community partnerships between
researchers and community-based organizations that impact the conduct of clinical and public health research
and support the Community Engagement Fellowship; and Aim 4) provide the infrastructure for training of early-
stage investigators with interest in EHS. The IHSFC facilitates the recruitment, evaluation, and assessment of
research subjects and supports imaging, cardiopulmonary physiology testing, biologic sampling, and tissue and
biospecimen procurement to attain these Aims. The IHSFC provides study design and data analysis assistance,
supports a Community Engagement Fellowship, and offers access to cutting-edge technology to evaluate and
analyze the effects of ambient air pollutants on lung structures. This technology can be applied to small animals
such as rodents, large animals such as pigs, and humans, promoting the translation of basic discoveries related
to environmental exposures to humans. Overall, the IHSFC integrates resources that facilitate clinical and
translational research studies within the EHSRC.